Nathan Shock Center for Excellence in Basic Biology of Aging

PROJECT SUMMARY / ABSTRACT OVERALL
Healthy aging is a complex process influenced by genetic, environmental, and life history factors that may
accelerate or delay aging and reduce or increase disease risk. Assessing the contribution of the myriads of
factors affecting aging requires an experimental model system to control unwanted variation and isolate
component effects while also reflecting the heterogeneity of human aging. The laboratory mouse has emerged
as the mammalian model system of choice for aging research. With this proposal, The Jackson Laboratory
Nathan Shock Center (JAX NSC) seeks to further develop and disseminate the next generation of genetic,
phenotyping, and information resources necessary to enable a deeper understanding of healthy aging. Over the
past 20 years, the JAX NSC has transformed aging research both at JAX and across the geroscience community
by providing resources to support investigators. This resulted in 20 peer-reviewed publications in the current
funding period. The Center has developed nascent regional and national resources for aging research, including
aged mice and tissues that support collaborations with internal and external researchers. All JAX NSC data and
protocols are disseminated through the Mouse Phenome Database and the JAX NSC website, ensuring that the
resources generated and expertise acquired through the Center are readily available to the aging research
community. In this renewal, we will build on the strength of past successes while also expanding the scope of
our experimental strategies, for example, to examine reproductive life history interventions in aged mouse
populations. We will develop and provide access to unique resources and tools, as well as provide support to
geroscience investigators by enabling them to leverage JAX’s unparalleled expertise in the characterization of
health and lifespan in aging mice. We will do this by providing effective Center administration and enhancing the
utility of JAX NSC resources throughout the aging community (Aim 1); expanding the research focus on aging,
late-life health and age-related diseases through a robust Research Development Core (Aim 2); increasing the
diversity of mouse resources available for aging research, including a new study to investigate the effects of
reproductive life history on the late-life health of female mice (Aim 3); strengthening the data and computational
support available to the aging community (Aim 4); and expanding the use of machine learning technologies to
the interpretation of aging pathologies (Aim 5). The Center will be led by a highly experienced team of Principal
Investigators and Core Leads who, with oversight from our External Advisory Board, will provide effective
management to facilitate the goals and objectives of the Center. The Center will leverage the world-class
institutional resources, facilities, and expertise of The Jackson Laboratory, a globally renowned institution for
mouse genetics research, to enhance its goals and maximize the utility of the resources it generates for the
broader geroscience research community.

Public health relevance
PROJECT NARRATIVE OVERALL Human aging is influenced by genetics, the environment, and life history factors that together determine longevity and late life health. The Jackson Laboratory Nathan Shock Center (JAX NSC) will develop resources, including aged mouse models and human-relevant phenotyping methods for dissemination to the geroscience research community. We aim to increase availability and scope of these critical experimental systems to accelerate the pace of aging research that will ultimately support healthy human aging.